Women, Intersectionality, Substance Use and HIV ( WISH)

PROJECT SUMMARY/ABSTRACT
The purpose of this Mentored Research Scientist Development Award (K01) is to provide the candidate with
the training and expertise needed to transition into an independent research career focused on intersectional
approaches to optimize HIV treatment and intervention. This K01 features a robust career development plan
and carefully linked research strategy. The overall objective of the research component of this K01 is to
examine how intersectional stigma and discrimination lead to inequalities in HIV treatment outcomes and
explore how resilience promotes engagement in HIV care among racially diverse women living with HIV who
use drugs (WLHIV-WUD) in the United States (US). This information will inform the selection and systematic
adaptation of an HIV-related evidence-based intervention (EBI) to facilitate engagement in care among
WLHIV-WUD. This will be achieved through the following three specific aims: 1) to assess the impact of stigma
and discrimination on inequalities in HIV treatment outcomes across intersections of drug use and race among
racially diverse WLHIV in the US; 2) to systematically adapt an HIV-related EBI to mitigate the impact of
intersectional stigma and discrimination and cultivate resilience to facilitate HIV care engagement among
racially diverse WLHIV-WUD in San Francisco, CA; and 3) to evaluate the acceptability and feasibility of the
adapted intersectionality-informed HIV care engagement intervention among racially diverse WLHIV-WUD in
San Francisco, CA. Dr. Jennifer Jain is the perfect candidate to conduct this research because of her strong
knowledge base in epidemiological methods and HIV and substance use research. During the 5-year award
period, Dr. Jain will achieve the following career development objectives: 1) gain content expertise in
intersectionality theory and research with an emphasis on HIV care engagement among WLHIV-WUD in the
US; 2) develop methodological expertise in advanced statistical techniques for quantitative intersectionality and
mixed methods; 3) acquire training in intervention science, including the adaptation and testing of evidence-
based interventions focused on HIV care engagement among WLHIV-WUD in the US; 4) build skills for a
successful independent research career, including grantsmanship, scientific manuscript writing and
collaborative cross-disciplinary research. This will be attained through the completion of a diverse set of
training activities including mentor-directed learning, formal course work, seminars, and real-world research
experience. The proposed research is highly consistent with current NIH priorities to: 1) conduct HIV-related
intersectional stigma research; 2) improve health outcomes among people living with HIV who use drugs; and
3) accelerate scientific discoveries in HIV/AIDS and substance use research. Moreover, this research supports
Dr. Jain’s pursuit of an independent career in research focused on intersectional approaches to enhance HIV
treatment and intervention among racially diverse WLHIV-WUD in the US.

Public health relevance
PROJECT NARRATIVE Although intersectional stigma and discrimination are critical barriers to HIV care engagement among women living with HIV who use drugs (WLHIV-WUD) in the United States (US), there is a notable lack of interventions that draw upon intersectionality to optimize HIV care in this population. This study will examine how stigma and discrimination lead to intersectional inequalities in antiretroviral therapy adherence and viral suppression and explore how resilience promotes HIV care, to inform the systematic adaptation of an HIV-related evidence- based intervention to facilitate engagement in care among racially diverse WLHIV-WUD in the US. Findings from this research will advance HIV treatment and intervention science by applying an intersectional framework and approach to improve HIV treatment outcomes and promote intersectional equity among WLHIV-WUD through the delivery of specialized intervention strategies.